High-Throughput Pulsed Stimulated Brillouin Microscopy for Cell Biomechanics

ABSTRACT
The mechanical properties of cells are critically involved in the regulation of numerous biological processes. This
has spurred the flourishing of mechanical testing methods for biomedical and biomaterial research in the past
three decades. Current instruments, though, require contact, are invasive, or are limited to the global analysis of
a sample. The goal of this proposal is the development of a novel optical microscopy modality for cell
biomechanics, based on pulsed Stimulated Brillouin scattering (SBS), which will be non-contact, to probe
different experimental settings beyond 2D cultures; non-perturbative, since cells are known to react to
mechanical stimuli; and, high-resolution, since biological cells are not homogeneous. In the past few years,
Brillouin microscopy has rapidly emerged, and its potential has been established in ophthalmology, tumor biology
and development biology. However, Brillouin microscopy has yet to reach widespread adoption for two main
challenges: acquisition speed still limited to ms/pixel and mechanical interpretation of the extracted signatures.
Based on strong preliminary data, here we plan to overcome these challenges with the development of novel
laser source and detection scheme for rapid SBS and the development of co-located maps of refractive index
and density to extract accurate mechanical information. In Aim 1, we will implement our technical innovations to
maximize the throughput of SBS microscopy, with an expected 100-fold improvement in acquisition speed
compared with current state-of-the-art. In Aim 2 we will validate the modulus estimation from SBS
characterization against gold-standard methods after uniquely factoring direct measurements of refractive index
and density. In Aim 3, we will field-test the high-speed SBS microscope for cell migration experiments where
biomechanics is known to be crucial but other mechanical testing methods are not feasible. This will both provide
quantitative feedback of performances to enable fine-tuning of the instrument development and demonstrate the
technology in settings that are familiar to the biological research community to facilitate communication of our
instrument features and adoption of our technology by the intended final users.

Public health relevance
PUBLIC HEALTH RELEVANCE This proposal will introduce non-perturbative elasticity-based characterization of biological cells. Brillouin technology will add a new mechanical modality to widely used optical microscopes currently capable of only structural/functional imaging. This will crucially advance the investigation of central questions in mechanobiology, i.e., how cells sense mechanical cues and transduce them into biochemical signaling, which are relevant for tissue morphogenesis, aging, diseases, and tissue engineering.